UCLA Career Development Program in Cancer Prevention and Control Research

DESCRIPTION (provided by applicant): At every phase along the cancer control continuum there are unanswered questions that challenge researchers in their battle against this disease. Over the past 10 years, the UCLA Career Development Program in Cancer Prevention and Control Research (R25) has successfully prepared promising post-doctoral scholars to meet these challenges by conducting transdisciplinary research that is critical to advancing the field. Our plan for a third program cycle builds on this experience and embodies our commitment to training the next generation of cancer control scientists by exposing them to the scope and diversity of this field, and the concepts, vocabulary, research skills, and analytical tools their work will require, with special focus on the needs of disadvantaged populations. It embodies continuity through maintenance of program elements that have successfully promoted the progress of twenty-seven post-doctoral fellows as reflected in their exemplary record of publications, receipt of research grants, and post-program academic and research placements. Our plan includes continued leadership by our experienced Directors guided by outstanding Advisory, Curriculum and External Advisory Committees, active involvement of a committed interdisciplinary group of 35 Core Faculty members and program location in the dynamic, interdisciplinary environment of the Jonsson Comprehensive Cancer Center and School of Public Health at UCLA. Fellows have access to the extensive resources at UCLA, including state of the art research facilities, vast educational opportunities, and community partnerships with organizations serving one of the most ethnically diverse populations in the nation. We will continue recruitment of an ethnically and disciplinarily diverse cohort of 6-8 outstanding post-doctoral fellows in order to promote the synergy that has been a hallmark of the program, and achievement by these fellows of core competencies through a structured but flexible program of coursework, mentored transdisciplinary research, conduct of pilot research guided by a primary and secondary mentor, publications and grant writing, and participation in symposia, workshops and other career-building activities. Based on a critical evaluation of our program, our plan for the next cycle also includes new and modified program elements that represent program change and growth: inclusion for the first time of 2-3 pre-doctoral fellows, expansion of a unique mini-course program that ensures exposure to new, emerging, cutting-edge issues as well as coverage of core content in the cancer prevention and control, enhancing links to Centers and Departments in our program environment, and revisions in our admissions and faculty orientation procedures that will further strengthen the program. Building on what has worked well and implementing innovative strategies will allow us to continue to achieve our vital mission: provision of a rich training program for future researchers so that they can and will successfully move our field forward.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal supports continuing the UCLA Career Development Program in Cancer Prevention and Control Research. The purpose of the program is to train transdisciplinary scientists to conduct cancer prevention and control research to reduce the population burden of this major disease. Public Health Relevance Statement This proposal supports continuing the UCLA Career Development Program in Cancer Prevention and Control Research. The purpose of the program is to train transdisciplinary scientists to conduct cancer prevention and control research to reduce the population burden of this major disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Commitment to training new scientists is a key prerequisite to progress in the rapidly changing, complex field of cancer control research. While excellent disciplinary training is vital in preparing future scientists, the traditional model in which researchers collaborate primarily with colleagues in closely allied fields, is no longer sufficient. Increasingly, transdisciplinary approaches are needed and the value of such approaches is likely to grow in the years ahead (Rimer, 2000; Emmons et al., 2008; Hiatt, Breen, 2008; Croyle, 2008). Social and behavioral scientists, epidemiologists, experts from the basic sciences of molecular biology and genetics, clinical specialists and public policy leaders find themselves collaborating with one another and with community partners as part of integrated research teams (Kerner, Guirguis-Blake, et al, 2005). Training must therefore involve innovative educational programs that expose scientists at a formative stage in their careers to the scope and diversity of this field, and the concepts, vocabulary, research skills, and analytical tools their work will require. Training must ensure that those entering this field embrace its transdisciplinary nature, and develop the perspectives needed to collaborate successfully with colleagues from a wide range of fields in order to address the many ongoing cancer prevention and control challenges (Kanavos, 2006). Responding to this need, we established the UCLA Career Development Program in Cancer Prevention and Control Research in 2000 (NCI R25T), and received support for a second five-year period in 2005. As we complete our first decade, we seek to build on the foundation we have created and renew and enrich our program for a third five-year cycle. We intend to retain those elements of our program that are effective, but also recognize the need for change in order to further strengthen our program. Our overall goal remains unchanged: to create a rich, transdisciplinary, structured yet flexible training experience that will produce well-rounded research scientists from diverse backgrounds with the expertise and ability to work effectively in collaborative settings needed to tackle complex cancer control issues. The specific aims of this program are: 1. to train 6-8 post-doctoral candidates and 2-3 pre-doctoral candidates over the course of the program from diverse disciplinary and ethnic backgrounds 2. to provide formal training in transdisciplinary cancer prevention and control including a specialized, tailored curriculum of coursework, research and laboratory experience, and participation in research seminars, workshops, and national scientific conferences and symposia 3. to provide an opportunity for each fellow to be actively involved in the research program of a senior faculty member who will serve as the trainee's primary mentor and as a research role model 4. to ensure research competence through completion, under the guidance of the primary and a secondary mentor, of a pilot research study with a translational, transdisciplinary theme resulting in published work and submission of grant applications Retaining the strong foundation we have created, and drawing on lessons learned during our first 2 cycles, we will further strengthen our program in the coming cycle by: admitting pre-doctoral fellows; expanding a new Seminar in Cancer Prevention and Control Research that has provided a unique source of learning and cohesion in our program; utilizing innovative mini-courses to explore important cutting edge themes and topics with our fellows; increasing our efforts to recruit minority fellows; revising admissions and faculty orientation processes to enhance successful fellow/mentor partnering; reorganizing leadership and committee structures to involve new faculty that have stepped forward with new ideas for our program; and strengthening linkages to Centers and Departments that are a vital part our program's setting.